B cell population structure in mouse and man

Abstract:
B cells are responsible for maintaining humoral immunity. However, a comprehensive spatial map of murine
and human B cell subsets across tissue compartments in the body is lacking. A barrier to these studies has
been the lack of methods for comprehensive analysis of large numbers of cells from many different tissues and
also access to rare human specimens. Here we use advanced computing and unbiased approaches to
organize B cell subset and their signaling properties in mouse and man. We will test the hypothesis that B cell
subset composition can be predicted by tissue site and that long-lived PCs in different tissues sites have
distinct regulatory programs that reflect their unique microenvironments. In Aim 1, we will establish the
population structure of murine and human B lineage subsets throughout the body using unbiased approaches.
In Aim 2, we will establish the tissue-specific regulatory programs and clonal relationships of murine long-lived
PC (LLPC) derived from two distinct microenvironments, BM versus gut. Results from this study will reveal the
global population structure of B subsets responsible for humoral immunity and provide insights into how B cells
control infections regionally and systemically.

Public health relevance
Project Narrative: Improving human health requires knowledge of which immune subsets are in different tissues and how these cells receive signals from the environment. Studies here will map B cell subsets across different tissue in mouse and man, and examine how tissue site of origin influences signaling pathways.